Molecular mechanisms of oral deficiencies in Down syndrome

Project Summary/Abstract: Individuals with Down syndrome (DS) contend with a diversity of oral
anomalies including poor saliva production and enamel defects that manifest as hypoplasia (thinner
enamel) and hypomineralization. The molecular mechanisms responsible for these alterations are not
known. DS enamel defects are developmental and not simply secondary to hyposalivation. Saliva is
essential to overall oral health, keeping the oral cavity moist and providing important support for speech
and taste. It also contains solutes and enzymes that help prevent bacterial attack. Tooth enamel and
saliva together provide a barrier against bacterial attack and can have a significant impact on health and
quality of life. Regulator of calcineurin 1 (RCAN1) is a gene on human chromosome 21 (Hsa21), trisomy
of which causes DS. RCAN1 is a feed-back inhibitor of calcineurin (Cn) a Ca2+-activated protein
phosphatase that is central to a diversity of intracellular signaling cascades. Loss of Cn function has been
shown to alter the water channel aquaporin, and in salivary glands, disrupts vesicle trafficking essential
for saliva protein secretion. The goal of this proposal is to understand how salivary gland and enamel
formation are altered in DS on a molecular level and to define the role of RCAN1/Cn in this process. In
strong support, our preliminary data show that Dp16 mice [Dp(16)1Yey] an established mouse model of
DS, have mechanically weak and morphologically abnormal enamel. We show that RCAN1 expression
is upregulated in the mineralization phase and that overexpressing RCAN1 in an ameloblast cell line
significantly alters mitochondrial function and increases ROS generation. Our co-investigator has
demonstrated that changes in RCAN1 gene dosage are sufficient to alter mitochondrial dynamics and
function in induced pluripotent stem cells (iPSCs) derived from individuals with DS. There are two central
testable hypotheses in the proposed studies: 1) RCAN1 disrupts enamel crystal formation in DS by
altering mitochondrial function in ameloblasts and 2) RCAN1 suppression of Cn signaling in DS
disrupts Ca2+ signaling in salivary glands leading to hyposalivation. We will use DS mouse models
(Dp16 mice, Rcan1-KO mice, Dp16 x Rcan1-KO mice) to address the role of mitochondria in the
ameloblasts of these mice and will use mice expressing fluorescently labelled secretory and maturation
stage. To address the role of RCAN1 trisomy in salivary glands (SG), we will use the Dp16 mice and will
cross them with GFP mice highlighting secretory vesicles in SG to analyze calcium signaling, salivation
as well as protein and solute content in saliva. The proposed studies are significant because they will
both advance our understanding of the mechanisms through which perturbation of normal mitochondrial
function, such as occurs in DS, can impact dental health ameloblast mitochondria and will elucidate the
mechanisms contributing to hyposalivation in DS.

Public health relevance
Project narrative Individuals with Down syndrome (DS) contend with a diversity of oral anomalies including poor saliva production and enamel defects. The molecular mechanisms responsible for these alterations are not known. We will use DS models and teeth from DS patients to address these oral defects.